Role of pathologic fibroblast subsets unique to silicosis

Abstract
Silicosis is a chronic and potentially fatal fibrotic disease caused by inhalation of crystalline silica. Recent
worldwide outbreaks of silicosis among workers who cut engineered stones for countertops underscore the
necessity of understanding the cellular and molecular mechanisms underlying silicosis, for which there is no
effective therapy. In silicosis lungs, activated fibroblasts generate granulomas called silicotic nodules and
persistently cause fibrosis, which deteriorates lung function over time. However, the mechanisms underlying
fibroblast activation and progressive fibrosis in silicosis have not been well studied. In previous work, we used
lineage tracing and single-cell RNA-sequencing (scRNA-seq) to show that alveolar fibroblasts are the major
origin of fibroblasts induced by bleomycin injury and in silicotic nodules in a murine model of silicosis. In
preliminary work that serves as the basis for this proposal, we revealed that, in response to silica, alveolar
fibroblasts differentiate into two unique populations that are not present in bleomycin-induced fibrosis or
idiopathic pulmonary fibrosis. One population is localized inside silicotic nodules, expresses high levels of ECM
genes, and is characterized by the up-regulation of ectopic bone regulatory pathways, which have recently
been shown to be important in driving silicosis. The other population is restricted to the periphery of silicotic
nodules and is characterized by hedgehog activation. This study takes advantage of our original mouse tools
that allow us to target each unique fibroblast subset specifically and aims to elucidate the lineage trajectories of
these fibroblast subsets and how they contribute to persistent fibrosis in silicosis. We hypothesize that
pathologic fibroblasts originating from alveolar fibroblasts in silicotic nodules utilize ectopic bone regulatory
pathways to cause a malicious feedback loop resulting in persistent fibrosis, while hedgehog-activated
fibroblasts restrict the expansion of silicotic nodules. In Aim 1, we will use our original mouse tools to lineage-
trace pathologic fibroblast subsets to elucidate the lineage trajectories and how pathologic fibroblasts in
silicotic nodules are maintained for chronic fibrogenesis. In Aim 2, we will conditionally delete bone regulatory
genes and the principal hedgehog receptor in alveolar fibroblasts to determine the roles of the pathways and
fibroblast subsets we found to be unique to silicosis. In Aim 3, we will build a fibroblast-centric cell atlas of
human silicosis with our specialized scRNA-seq strategy and high-throughput in situ hybridization to further
assess the translational potential of our murine studies. These studies should provide insights into the cellular
and molecular mechanisms driving silicosis, which could lead to novel therapeutic strategies for silicosis.

Public health relevance
Project Narrative Silicosis is a historically important occupational disease caused by inhalation of crystalline silica that currently lacks any effective treatment. In this study, we will aim to reveal the cellular and molecular details of pathologic fibroblasts, which accumulate and cause chronic fibrosis in silicosis lungs. If successful, our study may lead to novel therapeutic strategies to treat silicosis.